Inhibition of Fgr Prevents Pulmonary Fibrosis

Pulmonary fibrosis can arise spontaneously as in idiopathic pulmonary fibrosis (IPF), or following ionizing
irradiation, silica exposure, or COVID-19 infection. Senescence has been implicated in both radiation-induced
pulmonary fibrosis (RIPF) and IPF. Senescence precedes fibrosis in mouse RIPF and reported in COVID-19
patients. Clearance of senescent cells (SCs) by senolytic drugs present an attractive anti-fibrosis strategy.
However, senolytics may be non-specific and remove potentially beneficial as well as harmful SCs. Little is
known about how senescent cells induce pulmonary fibrosis. SCs exit cell cycle, induce p16, increase
senescence associated beta-galactosidase (SA-𝝱-gal), and secrete senescence associated secretory
phenotype (SASP) proteins. SASP include proinflammatory cytokines that may initiate and exacerbate fibrosis.
Therefore, using radiation as a model system to induce senescence, we propose to establish and validate a
specific mitigator of lung fibrosis by targeting one senescent protein while not removing the SCs. By RNA-seq of
pure SCs and by single cell RNA-seq (scRNAseq) of irradiated lungs, we discovered that tyrosine kinase Fgr is
highly induced in senescent cells. Fgr positive mouse lung cells induce biomarkers of fibrosis in vitro, and Fgr
inhibitor, TL02-59 treatment, abrogates the induction of profibrotic genes. Our preliminary data show: 1) in
mouse lung senescent cells, Fgr inhibitor TL02-59 abrogates the induction of profibrotic genes in target cells, 2)
in lung cells from Fgr knockout mouse, senescence occurs with radiation, but fail to induce profibrotic genes in
target cells, 3) human lungs from RIPF, silicosis, and IPF show induction of Fgr and senescent marker
p16, 4) TL02-59 reduces secretion of profibrotic SASP chemokines for attracting immunocytes, 5) inhibition of
Fgr in vivo, either by TL02-59, or by senescence inhibitor MMS350, reduces expression of fibrotic genes. We
hypothesize, Fgr in senescent cells initiates pulmonary fibrosis by secretion of proinflammatory SASP proteins
and by recruiting inflammatory immunocytes to the lungs. We further hypothesize that inhibition of Fgr by small
molecule TL02-59 or indirectly by the senescence inhibitor, MMS350, will prevent lung fibrosis. We will use
mouse primary lung cells from C57BL/6 control and Fgr knockout (Fgr-/-) mice to confirm the role of Fgr in vivo
in C57BL/6 and C57BL/6 Fgr-/- mice. Finally, we will establish that specific inhibition of Fgr prevents lung
fibrosis. Specific Aim 1 will establish that lung cell senescence induces Fgr and initiates pulmonary fibrosis
by the actions of secreted proinflammatory SASP and recruitment to the lungs of bone marrow
derived inflammatory cells. Specific Aim 2 will establish that Fgr is required for pulmonary fibrosis using Fgr -/-
mice. Specific Aim 3 will establish that specific and targeted pharmacologic inhibition of Fgr blocks lung fibrosis.
Our innovative approach will establish that Fgr induction in senescent lung cells
causes pulmonary fibrosis through secretion of proinflammatory SASP proteins and chemotactic recruitment of
inflammatory cells. Our proposed studies will lead to the development of a new mitigator of pulmonary fibrosis.

Public health relevance
Pulmonary fibrosis is a devastating disease that can arise from unknown causes (idiopathic), radiation, toxic chemicals, and most recently from COVID-19 infection and is shown to be mediated by senescence. We have shown that an enzyme called Fgr tyrosine kinase is elevated in lung senescent cells and blocking of Fgr reduces fibrotic properties of lung senescent cells. Now we will delineate the mechanism of senescence mediated lung fibrosis and establish that inhibition of Fgr using a small molecule TL02-59, will prevent pulmonary fibrosis and increase lifespan in mice, and will lead to a clinical trial to improve the lives of patients of pulmonary fibrosis.